Diversity, Equity and Inclusion: Developing a research agendafor addressing Racism in Emergency Medicine

PROJECT SUMMARY/ABSTRACT
Racism has had a profound effect on healthcare outcomes, as well as influencing social determinants of
health. Despite the dramatic data around these disparities, research into the effect of racism and tangible
steps towards mitigation of racism on healthcare have lagged behind traditional research. Although Emergency
Medicine is a field that generally focuses on acute injury and illness, it also has a distinct social and statutory
mandate to treat everyone, regardless of socioeconomic status, as well as the role as a gatekeeper to further
care. As such, Emergency Departments (EDs) disproportionately care for vulnerable and underserved
communities, and are uniquely situated to be focused on racial inequities, including social determinants of
health, such as unstable housing, food insecurity, and interpersonal violence. It is crucial that we examine how
race affects healthcare in all aspects, from clinical outcomes, to recruitment into the medical profession, to
training, to retention, to promotion. In order to propel an evaluation of race in Emergency Medicine forward
and address ways in which Emergency Medicine can more effectively identify and intervene to address racism,
we propose a Consensus Conference, “Diversity, Equity and Inclusion: Developing a research agenda for
addressing Racism in Emergency Medicine.” The Society for Academic Emergency Medicine (SAEM) has
successfully led twenty prior annual consensus conferences, and has assembled a diverse group of content
experts, researchers, policymakers, and other key stakeholders. The consensus conference has three specific
aims: (1) Identify best practices, clarify knowledge gaps, and prioritize research questions pertaining to
Diversity, Equity and Inclusion (2) Bring together key stakeholders with varied backgrounds to promote
collaboration and develop new research partnerships; and (3) Disseminate findings of the consensus
conference and evidence-based practices through peer-reviewed publications, digital media, community-based
organizations, and other diverse venues. This conference will result in a Diversity, Equity and Inclusion
research agenda that supports future interdisciplinary research that aims to reduce health disparities and
improve health outcomes for vulnerable populations, as well as changing the face of Emergency Medicine.

Public health relevance
PROJECT NARRATIVE Health outcomes and health care utilization patterns of U.S. Emergency Departments varies disproportionately by race and we aim to examine the different aspects of how race influences the utilization and outcomes of emergency care. We propose a consensus conference – Diversity, Equity and Inclusion: Developing a research agenda for addressing Racism in Emergency Medicine – to support the development of a consensus-driven research agenda, research collaboration network, and dissemination plan for evidence-based practices related to the care of health disparity populations in emergency care settings.